Determination of genetics of childhood onset hypertension

DESCRIPTION (provided by applicant): The candidate, Dr. Monesha Gupta is a pediatric cardiologist/hypertension specialist and is currently an Assistant Professor in Pediatrics at the University of Texas Health Science Center- Houston [UTHSC-H] and serves as the director of the Pediatric Hypertension Progam. The proposed training plan will foster the candidate's scientific and clinical research expertise thus leading to an independent career in genetics & patient oriented research. Mentors include Dr. Sanjay Shete [genetic biostatistician], Dr. Dianna Milewicz [cardiovascular geneticist], Dr. Eric Boerwinkle [hypertension geneticist], Dr. Jacqueline Hecht [pediatric geneticist] and Dr. Michelle Barratt [pediatrics and ambulatory care clinical specialist], all of the UT-Houston. There is a paucity of evidence concerning essential hypertension in the pediatric population where prevalence approximates 11% to 13%. Inadequate evidence is likely due to: 1) Greater variability in parameters and complexity of evaluation and diagnosis in pediatric populations, and 2) Higher prevalence of secondary causes contributing to the hypertension diagnosis. In addition to the proposed training regimen, Dr. Gupta will examine heritability of pediatric essential hypertension. It is hypothesized that heritable, rather than environmental factors, are the primary determinants of essential hypertension in children. The overall goal is to precisely characterize and phenotype essential hypertension in a pediatric population and determine the role of genetic and environmental factors. This will be accomplished by systematically ascertaining children with essential hypertension followed by: a) full demographic profile b) complete family history c) three generation pedigrees for each proband and d) subphenotyping for obesity and salt sensitivity. Family-based case control data sets offer many advantages for investigaing genetic & environmental susceptibilty factors of a disease. A cohort of 300 affected non-Hispanic White, African American, Hispanic and other children and their first degree relatives will form the database. A control population of 300 unaffected & unrelated children will also be obtained. DNA samples will also be collected from consenting/assenting subjects and banked for candidate gene analysis and other future genetic testing. This study will contribute to understanding underlying pathophysiology of this complex multifactorial disorder in children and contribute to identification and treatment of an at-risk population earlier in childhood. Besides determining the genetics of pediatric hypertension, the candidate will also receive advanced education in biostatistical and genetic methods to be able become a accomplished childhood hypertension expert, during the proposed study.

Public health relevance
Project Narrative Unlike adult essential hypertension, childhood-onset essential hypertension is not a well-defined entity. Thus, determining the genetic make-up of a tri-ethnic population will be an important first step. The possibility exists that in the future some forms of genetic treatment will allow a better and prolonged control of and prevents the damage related to hypertension.